Data Science Core

Modified Project Summary/Abstract Section

MONTANA INBRE DATA SCIENCE CORE SUMMARY
Increasingly, biomedical research depends on local capacities to rapidly generate, analyze, and disseminate information emerging from large and complex datasets. The MT INBRE Data Science Core (DSC) will provide technical support and facilitate access to resources necessary to ensure researchers across the MT INBRE network can employ leading-edge computation, cloud, and data collection and management strategies, including those for community data. The DSC also will provide increased experiential training opportunities for students. Training efforts will be aligned with Data Science (DS) programs at Montana Technological University (MT Tech), Montana State University Bozeman (MSU), and the University of Montana (UM), while responding to self-identified needs across the state through on-site and remote train-the-trainer workshops at all network partners. A major strength of the MT INBRE DSC is its capacity to support research projects throughout Montana while also collaborating with the training efforts of the Regional Alliance of INBRE Networks (RAIN) to take advantage of and contribute towards regional resources.

The efforts and direction of the DSC will be guided by four Aims: Specific Aim 1. Position Montana faculty and students to be leaders in computational science, big data analysis, and artificial intelligence by improving infrastructure and access to resources. Specific Aim 2. Expand capacity for the collection and application of community data geared toward improving the health of all Montanans. Specific Aim 3. Build regional data science expertise by providing experiential training opportunities to students and faculty. Specific Aim 4. Contribute to Western IDeA regional efforts to develop data science expertise and capacity throughout the RAIN network.